Combined guanfacine and mindfulness meditation as an adjunct to buprenorphine maintenance in OUD

PROJECT SUMMARY
The US is currently going through an opioid crisis, and while Medication Assisted Treatments such as
buprenorphine (BUP) have proved highly effective at stabilizing the neurobiology underlying acute withdrawal,
they have been less effective at preventing longer-term relapse and adherence. This may be due to the fact
that they do not fully engage the neural processes sub-serving the emotional control of sensitized negative
mood and reward sensitivity during stress- and opioid-cue provocation, respectively. In contrast while the
alpha2 agonist, guanfacine, may attenuate stress-provoked opioid craving by mediating top-down prefrontal
control over sensitized dysphoria, the behavioral intervention, Mindfulness Oriented Recovery Enhancement
(MORE) may reduce opioid cue-provoked craving by mediating top-down prefrontal control over hedonic
dysregulation. Furthermore, while both interventions separately may prove effective as longer-term adjunctive
therapies, they may offer greater efficacy together, providing a unique medication/behavioral combination able
to target both stress and reward provocation mechanisms. To optimally test this hypothesis, a staged approach
is proposed to first confirm the efficacy of both GXR and MORE, independently and combined (R61), prior to
elucidating underlying neural mechanisms (R33). Using a 2 X 2 design, N=80 OUD individuals on
Buprenorphine (BUP) will be randomized to either 6-weeks of Guanfacine extended release (GXR; 3mgs,
n=40) or placebo (PBO; n=40). Half of all participants in each group will then receive either weekly MORE, or a
Support Group (SG) control, creating four intervention groups (Control Grp: PBO+SG, n=20); (GXR Grp:
GXR+SG, n=20); (MORE Grp: PBO+ MORE, n=20); (Combined Grp: GXR+MORE, n=20). A pre- and post-
laboratory study will be conducted before and after six weeks of intervention where participants will be
randomly exposed to 3 personalized guided imageries (stress, opioid cue, neutral). Subjective measures of
opioid craving, anxiety, mood, stress, emotional reappraisal, and heart rate will be collected before and after
imagery exposure. Following milestone completion, an identical design is proposed in N=144 individuals,
where participants will be exposed to imageries in the scanner (R33). On the basis of prior research, it is
hypothesized in that GXR will attenuate opioid craving and improve emotion regulation during stress, while
MORE will demonstrate the same effects during opioid cue exposure. GXR and MORE will also demonstrate
additive or synergistic improvements compared with each intervention alone (R61). The effects of GXR on
opioid cue- and MORE on stress-provoked opioid seeking will be explored. In the R33 component, it is
hypothesized that GXR will improve regulatory and affective brain function during stress, and MORE will
improve regulatory and reward function during opioid cue exposure. Combined GXR and MORE may improve
regulatory function in an additive or synergistic manner (R33). Findings will help elucidate the efficacy and
neural mechanisms underpinning a novel integrated pharmaco-behavioral therapy for OUD individuals
maintained on BUP.

Public health relevance
Project Narrative Opioid addiction has taken a form of epidemic in the U.S., resulting in a high number of opioid related overdose deaths. While opioid maintenance provides the gold standard treatment for opioid use disorder (OUD), it has been unsuccessful to prevent relapse to short acting opioids and other substances and to keep OUD individuals in treatment for long-term. In this application, we propose that a combined guanfacine and mindfulness therapy as an adjunct to buprenorphine maintenance therapy will improve stress provoked craving and opioid cue provoked craving compared to guanfacine alone or mindfulness alone treatment in OUD individuals, and thus will ultimately reduce relapse to illicit drugs and enhance treatment retention.